Defining the architecture and activation mechanisms of SynGAP

Project Summary
Excitatory synapses exhibit characteristic proteinaceous microcompartments at the membrane known as
the post-synaptic density (PSD). The PSD is richly organized into multi-protein complexes composed of
glutamate receptors, scaffolds, cytoskeleton, and signaling effectors. The dynamic reorganizations of the
higher-order architecture and composition of PSD signaling complexes underlies synaptic plasticity,
learning, and memory. Dissecting the interactions and allosteric communication mechanisms of the PSD
is a prerequisite for understanding the molecular underpinnings of synaptic plasticity. Synaptic signaling
complexes are large and highly dynamic, problematic targets for mainstay structural biology approaches.
The overarching goals of this project are to surmount the challenges of structural characterization of
PSD signaling complexes by applying a battery of protein footprinting, spectroscopies, chemical tools,
and proteomics approaches to probe protein structure in biologically relevant milieu. This project
focuses on the architecture, activation mechanisms, and scaffolding roles of SynGAP, an abundant PSD
GTPase-activating protein. SynGAP is critical to brain development, long-term potentiation, and spatial
learning. Importantly, SynGAP mutations in humans are associated with autism spectrum disorders,
schizophrenia, and intellectual disability. Despite its ubiquity and central signaling role, the architecture
and signaling mechanisms of SynGAP remain largely unknown. Defining the molecular mechanisms of
SynGAP signaling is critical for understanding the basis of brain disorders caused by SynGAP
dysfunction. Hybrid structural biology approaches will be integrated to build a structural model of the
multi-domain holoenzyme. These approaches are uniquely amenable to characterizing dynamic protein
interfaces and conformational changes in solution. Phosphorylation-induced conformational changes
will be defined to determine activation mechanisms. SynGAP apparently regulates opposing pathways
dictating synaptic strength via dual specificity toward both Ras and Rap. Specificity switching
mechanisms will be revealed by mapping structural determinants of Ras and Rap interactions. By
dissecting the structural basis for SynGAP function the proposed research will be a vital contribution to
the ongoing movement to characterize the molecular architecture of the PSD. Resolving SynGAP
signaling complex structure and mechanisms will clarify the basis of SynGAP-linked neuronal disorders
and spur the development of future therapeutics.

Public health relevance
Project Narrative Regulators of small GTPases play a central role in tuning the strength of synaptic connections. The aims of this project focus on defining the activation mechanisms and allosteric regulation of a prominent negative regulator of both Ras and Rap signaling. The proposed research is relevant to public health because delineating the regulatory mechanisms of synaptic signaling is a prerequisite to developing therapeutics and biomarkers for the mental health disorders that arise from its dysfunction.